The Influence of Lifetime Occupational Experience on Cognitive Trajectories Among Mexican Older Adults

PROJECT SUMMARY
This F31 research and training program will contribute to research on occupation as a life course determinant
of late-life cognitive function in low- and middle-income countries (LMICs). The program will prepare the trainee
for an independent research career, specifically to conduct life course and social epidemiology research
among aging populations in LMICs and underrepresented U.S. populations. The training plan aims to achieve
(1) expertise in life course determinants of cognitive aging, (2) advanced proficiency in life course epidemiology
methods, and (3) enhanced scholarly productivity and professional development. The trainee will work under
the guidance of a Sponsor and Co-Sponsor, incorporating collaborators from multiple disciplines to ensure
diversity in training, research, and professional networking. The research project examines life course
determinants of cognitive function in late life, which can help identify long-term risk and protective factors
among aging populations. In high-income countries, occupational complexity predicts better cognitive function
in late life. This association, however, is understudied in LMICs because of the lack of objective measures of
occupation complexity and longitudinal aging studies
. The Mexican population, like many other LMICs
, ages in
the context of changing social and economic environments, and little is known about how these changes
influence cognitive function trajectories. This project will use waves 1 to 6 (2001-2021) from the Mexican
Health and Aging Study (MHAS), a nationally representative longitudinal aging study, to examine the influence
of lifetime occupation on cognitive function trajectories among a national sample of Mexican adults aged 50
and older. Unique to this study is the inclusion of women who are housewives. Another innovative aspect of
this project is the use of a linkage between the MHAS occupations and the Occupational Information Network
(O*NET), a database with occupation-specific descriptors, such as mental demands to perform the job. Using
the MHAS, this project will achieve the following aims: (1) Describe the lifetime occupational biographies of
older adults in Mexico; (2) Examine the association between lifetime occupation mental demands and
trajectories of cognitive function in old age; (3) Evaluate the combined effects of lifetime occupation and family
transitions on late-life cognitive function for men compared to women. Occupational biographies include details
such as occupation type, age at first job, number of years at work, if the participant ever migrated to the United
States for work, and work benefits across the life course. Latent growth models will be used to identify the
influence of mental demands of work on the cognitive trajectories of Mexican older adults. Groups based on
family-work transitions, such as marrying early or late and entering the labor force early or late, will be created
and used to identify how group membership affects cognitive trajectories in old age. The findings will explain
how cognitive trajectories are influenced by occupation and how this effect varies for men and women due to
gender differences in family-work transitions.

Public health relevance
PROJECT NARRATIVE The proposed research and training program will contribute to the trainee’s independent research career as an investigator of life course experiences and their effects on cognitive aging. The research project will describe the occupational experiences of Mexican older adults and explain how the mental demands of lifetime occupation influence cognitive trajectories for men and women. Results from this study will advance knowledge of the effects of social life course factors on health outcomes in aging and inform policy on occupation and health in low- and middle-income countries like Mexico.